Characterizing Vancomycin-Resistant C. difficile Strains at Two Geographically Distinct Locations

PROJECT SUMMARY
Clostridioides difficile infection (CDI) is the leading cause of antibiotic-associated diarrhea and death worldwide. As
a result, the U.S. CDC has classified C. difficile (CD) as an urgent public health threat. Recent guidelines from
Infectious Diseases Society of America and Society for Healthcare Epidemiology of America recommended oral
vancomycin or fidaxomicin for both non-severe and severe CDI cases. Because of the high cost of fidaxomicin,
vancomycin is now the drug of choice, making it the most important antibiotic for the treatment of CDI.
The foundation for this work is based on our recent discovery of CD strains in patients from Texas and
Kenya exhibiting reduced susceptibility to both metronidazole and vancomycin. We examined diarrhea CDI
stools from 438 patients from Texas and 98 from Kenya for the presence of metronidazole- and vancomycin-non-
susceptible CD isolates. Of the stools from Houston, 114/438 (26%) grew CD isolates that were not susceptible to
vancomycin, 128/438 (29%) to metronidazole, and 97/438 (22%) to both metronidazole and vancomycin. Among
the Kenyan patients, 66/98 (67%) were not susceptible to vancomycin, 83/98 (85%) to metronidazole, and 57/98
(58%) to both antibiotics. Alarmingly, many of the isolates from both locations showed levels of non-susceptibility to
these antibiotics that far exceeded their known MICs. Whole-genome sequencing showed the presence of
homologs of vanA and vanB gene clusters, common mediators of high-level vancomycin resistance in many
hospital-associated pathogens. Until now, such high-level vancomycin non-susceptibility has not been reported in
CD strains. The spread of CD strains resistant to vancomycin, a front-line antibiotic for this life-threatening
pathogen, will have serious clinical and public health implications. This underscores an urgent need for a
comprehensive analysis of the circulating strains, mechanisms of resistance, and how it impacts clinical outcomes
to help inform clinical decisions. Our preliminary evidence strongly supports the hypothesis that vancomycin
non-susceptible CD strains may be widespread in the CDI patient population and that strains circulating on
the African continent may be genetically different from strains circulating in North America. To investigate
this hypothesis, we will (i) assess the proportion of CDI patients from Texas and Kenya infected with vancomycin
non-susceptible strains and compare the infecting strains; (ii) characterize the genetic elements associated with
vancomycin non-susceptibility; and (iii) prospectively follow CDI patients infected with vancomycin non-susceptible
strains to assess disease severity, clinical outcome, and rate of recurrence of the infection following treatment.
Due to the current importance of vancomycin in CDI treatment, the proposed research will have a major
impact on clinical decisions. Importantly, the genetic elements responsible for high-level vancomycin non-
susceptibility in CD strains and how it impacts disease severity, clinical outcome, and treatment will be
established. This will provide insight into the extent of resistance and open up new avenues for long-term
preventative and interventional strategies to mitigate deaths associated with this life-threatening pathogen.

Public health relevance
PROJECT NARRATIVE Vancomycin is currently the drug of choice and the most important antibiotic for the treatment of CDI. However, C. difficile strains with decreased susceptibility to vancomycin have emerged in the patient population. The goal of this project is to establish the proportion and characterize the genetic elements responsible for vancomycin non-susceptibility in C. difficile isolates in patients from two geographically distinct locations, and assess the impact of vancomycin non- susceptibility on clinical outcomes.